PET imaging of presynaptic nigrostriatal dopaminergic function in optimally treated HIV+ patients

We have received IRB approval to start recruiting patients in July 2018. We started imaging on 11/20/2018. We finished recruitment and scanning on January 2022.
IN total, we recruited a total of 38 subjects who have undergone one scan (Only FDOPA scan, n=1, only DASB scan, n=2) or two scans (FDOPA and DASB, n= 35)
Imaging the dopaminergic system:
1. Group A: 20 patients with HIV infection
2. Group B: 11 subjects without HIV infection with at least one co-morbidity
3. Group C: 10 patients without HIV infection without co-morbidities.

Imaging of the Serotonin transporter (SERT using 11C-DASB).

1. Group D: 18 patients with HIV infection.
2. Group E: 22 patients without HIV infection.